MYCOPHENOLATE MOFETIL IN RENAL TRANSPLANT

The purpose of this small project is to ensure that the assay which will measure inosine monophosphate dehydrogenase (IMPDH) activity in whole blood at trough and peak drug level has been adequately tested prior to enrolling patients in the larger study. Adult renal transplant patients who are currently taking Mycophenolate Mofetil(Cellcept) will be asked to participate in testing the assay. Five patients, selected at random from those in clinic who are already scheduled to have blood work drawn will be asked to donate an additional 5ml of blood to measure IMPHD activity at trough and peak drug levels. This blood will be drawn prior to taking their morning dose of Cellcept, and again 2 hours post dose. The only additional risk of discomfort to the patient associated with this procedure will be the additional blood drawn 2 hours post dose. Each patient who consents to have this additional blood drawn will be compensated $20 for their time and participation